Influence of Temporal Difference Reward Prediction Errors on Brain Network Connectivity during Learning and Decision-Making

PROJECT SUMMARY
Disorders of choice behavior, such as substance abuse and impulse control disorders, involve over-valuing and
repeatedly choosing certain reinforcers (e.g., drugs, risky actions), even in the face of recurring consequences.
Understanding the link between adaptive choice behaviors and underlying neural activity is a strategic focus for
substance abuse and mental health research. Much empirical evidence demonstrates that features of distinct
pathological behaviors map onto distinct patterns of interactions between distributed brain regions. Nevertheless,
how adaptive learning signals concerning rewards and punishments alter region-to-region functional interactions
in real-time lies at the limit of our current understanding. As such, we seek to identify neurobehavioral markers
that reflect how reinforcement learning (RL) signals alter functional brain network interactions and associated
choice behaviors in healthy adults. Along this line of inquiry, this proposal’s central objective is to understand
how real-time changes in inter-regional functional interactions – between, for instance, regions of the basal
ganglia and limbic, prefrontal, and sensorimotor cortices – in response to RL signals influence adaptive choice
behaviors. Our approach uses computational methods to investigate the quantitative relationship between
measures of human choice behavior and brain network interactions at high-resolution spatiotemporal scales.
Specifically, we pair computational RL models of human behavior on a probabilistic reward and punishment
learning task with multi-modal functional neuroimaging to investigate changes in functional brain networks
responsive to learning signals called ‘temporal difference reward prediction errors’ (TD RPEs). We will identify
functional network interactions related to TD RPE signals to address, through two Specific Aims, our overarching
hypothesis that TD RPE signals alter – in real time – the coupling (synchrony) of functional interactions between
brain regions involved in processing rewards and punishments to direct changes in choice behavior. In Aim 1,
we will measure functional networks interactions using magnetoencephalography (MEG) to test the hypotheses
that (1) positive TD RPE signals increase, in real time, the coupling of inter-regional functional interactions and
(2) negative or zero TD RPE signals decrease this coupling. In Aim 2, we use functional magnetic resonance
imaging (fMRI) – within the same subjects from Aim 1 – to investigate individual-specific functional networks
associated with TD RPE signals. Here, we will localize TD RPE-responsive functional regions-of-interest (ROIs)
and incorporate these ROIs as individual-specific spatial priors for within-subject MEG analysis of functional
network interactions. In all, this fellowship will provide training in contemporary modeling methods and
experimental design that address fundamental questions in computational neuroscience regarding the functional
organization of the human brain during adaptive learning. The central findings of this research will advance our
understanding of the principles of brain activity supporting adaptive learning processes that are characteristically
the root cause of many behavioral symptoms of substance abuse and related behavioral disorders.

Public health relevance
PROJECT NARRATIVE Humans with substance abuse or behavioral disorders demonstrate patterns of choices that depend on how they learn from rewards and punishments that follow from their actions, and the principles of whole-brain neural activity associated with learning from reinforcement remain incompletely understood. Accordingly, this study pairs human fMRI and MEG neuroimaging with behavioral measures and computational modeling to investigate how functional interactions within brain networks change during adaptive decision-making. The findings generated from these studies will provide new insights into the patterns of neural activity underlying adaptations in choice behavior involved in addiction and related behavioral disorders.